Novel Aspects of Hepatic Mitochondrial Amino Acid Metabolism

Project Summary/Abstract
The production of glucose by the liver is a vital physiological process. Hepatic glucose production plays
an important role in regulating normoglycemia during starvation, providing skeletal muscle with glucose
during exercise, and contributing to hyperglycemia of diabetes. Gluconeogenesis, the process of converting
the carbon in pyruvate, lactate, or amino acids into new glucose, plays an important role in glucose
production by the liver. Gluconeogenesis requires the transport of pyruvate or amino acids across the
impermeable inner mitochondrial membrane (IMM) and subsequent metabolism by enzymes exclusively
localized to the mitochondrial matrix. Recent work from the laboratory of the applicant has demonstrated an
important role for the mitochondrial pyruvate carrier (MPC) complex in gluconeogenesis from
pyruvate/lactate. However, these studies also suggested an important role for pyruvate-alanine cycling as a
compensatory mechanism when MPC activity was impaired. In addition, while amino acids like alanine are
believed to be an important substrate for gluconeogenesis, many details regarding their metabolism are
lacking. The significance of the proposed studies is that we will dissect the molecular mechanisms that
mediate these processes in fasting, exercise, and diabetes. We hypothesize that the transcription factor
ATF4 will regulate the expression of alanine transaminase 2 (ALT2) and that this enzyme will play an
important role in regulating alanine-stimulated gluconeogenesis in diabetic liver (Specific Aim 1). We also
hypothesize that that the effects of ALT2 deficiency on glucose production will be enhanced by concomitant
loss of MPC activity to disrupt gluconeogenesis from both alanine and pyruvate. (Specific Aim 2). We also
propose a third, exploratory Aim that has the potential for marked scientific advance. The transport of alanine
across the impermeable IMM by a carrier-mediated process is required for alanine to be used for
gluconeogenesis. However, the identity of the carrier that mediates this process has never been determined.
We hypothesize that the yeast Avt5 and its mammalian homolog Slc38a10 serve as the mitochondrial
alanine carrier and that these proteins are required for mitochondrial alanine metabolism (Specific Aim 3). We
believe that the proposed studies will provide marked scientific advance towards our understanding of hepatic
amino acid metabolism, which has been understudied to this point. In addition, these studies will provide
insight into the effects of these metabolic pathways on hepatic gluconeogenesis and could impact
pharmaceutical development of new drugs to treat diabetes.

Public health relevance
Project Narrative The goal of this project is to study the molecular mechanism that regulate metabolism of amino acids and carbohydrates in the liver. Successful completion of these studies will provide new information about how the liver regulated metabolism of these nutrients and may pave the way to clinical development of new drugs to treat diabetes.